Project 1: Tumor Microenvironment Initiators of the Metastatic Cascade in High-Risk Prostate Cancer

PROJECT SUMMARY
There is an increasing incidence of men with newly diagnosed prostate cancer (PC) presenting with locally
advanced or metastatic disease, a population that comprises >60% of the men who die from the disease. The
failure of early detection has led to the initiation of multiple clinical trials testing neoadjuvant therapies in an
attempt to cure these patients. Analysis of pre-treatment samples from neoadjuvant trials have identified genomic
alterations that associate with a treatment resistance. More recent studies indicate the tumor microenvironment
(TME) can initiate the metastatic cascade. However, it remains unclear how and when genomic alterations co-
opt different cell types in a complex 3-dimensional TME to initiate the metastatic cascade. We have recently
found that activated fibroblasts and macrophage sub-populations induce lymphovascular sprouting and
permeability. Based on these data sets, we hypothesize that somatic alterations in tumor DNA co-opt
stromal and immune cells in the TME to promote invasion and intravasation of lympho-vascular
channels. To test this hypothesis, we have three cohorts of patients with high-risk prostate cancer (surgery
alone, neoadjuvant Abiraterone, and neoadjuvant chemohormonal therapy) that undergo PSMA PET/MRI scans
prior to surgery. This scan is used to develop 3D mold of the prostate to perform whole mount sectioning and
dissection of multi-focal PC for multi-plex molecular analysis. Samples from these specimens are used to create
patient-specific “TMEs on a Chip” using a humanized Micro-Physiologic System (MPS) of the prostate with
surrounding lympho-vasculature. This novel model system allows culture of patient tumor cells and stromal cells
to identify the factors that induce lymphatic permeability and culminate in tumor invasion and intravasation.
Success in these studies will identify the biologic interactions in the TME that can initiate the metastatic cascade
as potential biomarkers and therapeutic targets for men with high-risk, locally advanced PC. In Aim 1 we will
perform whole exome and transcriptome sequencing, across 3D whole mount sections identified by PSMA
PET/MRI, in untreated patients to evaluate heterogeneity and determine the impact of neoadjuvant ARSIs and
docetaxel across 3D multifocal PC. In Aim 2, we extend spatial mapping with PSMA PET/MRI and IHC data to
perform transcriptional Digital Spatial Profiling (DSP) on whole-mount sections collected in Aim 1. This
integration will test whether distinct CAF and immune cell infiltrates associate with genomic alterations in a spatial
configuration of cells invading regional lymphovascular channels. In Aim 3, we use LumeNEXT MPS technology
to create humanized lymphatic vessels cultured in patient-specific humanized prostate TMEs, with genomically
engineered PC cells, that reflect the molecular and cellular signatures identified in Aims 1 and 2. When
completed, the outcome of this work will advance the field by helping us to understand how prostate cancer
metastasizes for both biomarker and drug development.

Public health relevance
Project Narrative There is a critical need to understand the initial biologic steps that lead to invasive and metastases in locally advanced prostate cancer, a disease state which accounts for >60% of men who die from the disease. We have developed complementary technologies to identify and analyze patient tumors using a new microphysiologic system of lympho-vascular invasion. These tools are deployed in two prospective patient cohorts to study underlying mechanisms of metastases, identify new biomarkers and develop new therapeutic strategies for this patient population.